Prospective Validation of Neurophysiologic Outcome Prediction in Acute Brain Injury

PROJECT SUMMARY
Acute brain injury causes over 163,000 deaths in the US annually and leaves many more patients with long-
term disability. Preventing secondary brain injury is critical to improving neurologic outcomes in these patients.
Pathological brain electrical activity (measured via EEG) following acute brain injury contributes to long-term
disability via seizures in the acute phase and epilepsy in the chronic phase. EEG is the primary tool for
monitoring aberrant brain activity, yet it is underutilized due to uncertainty regarding the clinical significance of
EEG findings and the high workload associated with interpreting high volumes of EEG data.
Our group has made progress toward addressing these short-comings by developing three novel machine
learning algorithms: 1) a seizure forecasting model for hospitalized patients (“2HELPS2B”); 2) a model that
measures the Burden of Epileptiform Activity (EA—seizures and highly epileptiform patterns such as lateralized
periodic discharges) to predict neurologic outcomes (“BEACON”); and 3) A model that uses EA in the acute
phase of brain injury to predict the risk of developing epilepsy.
This proposal is the culminating step required to translate preliminary studies into actionable clinical tools. In
this prospective multicenter observational study, we will collect clinical and EEG data on 3000 patients with
acute brain injury to further develop and validate these models. Our study leverages an existing multicenter
bioinformatics infrastructure and established collaborations between Yale University, University of Wisconsin,
and Massachusetts General Hospital, to create the scale and quality of data needed to address three specific
aims: SA1: Develop and prospectively validate an automated in-hospital seizure-forecasting model for use in
acute brain injury, based on our previously developed 2HELPS2B score—termed auto-2HELPS2B; SA2:
Prospectively validate the BEACON model for the impact of prolonged epileptiform activity on functional and
clinical outcomes in critical illness at discharge, 3 months, 6 months, 1-year, and 2-years, and estimate the
optimal anti-seizure drug administration strategy (indications and intensity of drugs) to mitigate detrimental
effects of EA on functional and clinical outcomes; SA3: Prospectively validate EAs as a biomarker of 1- and 2-
year epilepsy risk after acute brain injury, evaluate effects of anti-seizure drugs on acute phase EAs and
subsequent development of epilepsy, and combine EEG with radiographic and clinical information to further
improve our current epilepsy forecasting risk model.
Upon completing these aims, we will have 1. A large and representative database of high-quality EEG and
clinical data on brain-injured patients with 2-year of outcomes data. 2. Validated EEG tools to guide care in
determining acute seizure risk, prognosis for neurological recovery, and the likelihood of developing epilepsy.

Public health relevance
Project Narrative In this prospective multicenter observational study, we will collect clinical, EEG, and 2-year neurologic outcomes data for 3000 patients with acute brain injury, in order to validate three novel machine learning models for future use in clinical trials and clinical care: 1) a seizure forecasting model (“2HELPS2B”); 2) a model that predicts the effect of the Burden of Epileptiform Activity on Neurologic Outcomes (“BEACON”); 3) a model that uses properties of epileptiform EEG abnormalities in the acute phase of brain injury to predict the risk of developing chronic epilepsy. Deliverables will include a large, public database of high-quality EEG and clinical data on brain-injured patients with 2-year of outcomes data, and validated EEG tools to guide care and improve outcomes for patients recovering from acute brain injury.